Clinical Protocol and Data Management

PROJECT SUMMARY/ABSTRACT - CLINICAL PROTOCOL AND DATA MANAGEMENT (CPDM)
The overall goal of Clinical Protocol and Data Management (CPDM) is to establish and maintain central
management and oversight functions for coordinating, facilitating, and reporting cancer clinical trials by the
University of Chicago Medicine Comprehensive Cancer Center (UCCCC) in a scientifically rigorous and
regulatory-compliant manner. This goal is carried out through the Clinical Trials Support Office (CTSO) that
oversees a broad portfolio of trials including investigator-initiated clinical trials (IITs), trials through the
National Clinical Trials Network (NCTN, ETCTN) and other NCI-sponsored clinical trials, and industry-
sponsored clinical trials. The CTSO is committed to supporting high-quality clinical trials with equitable
access throughout the UCCCC catchment area. The Specific Aims of the CPDM program are to (1) Provide
centralized oversight, management, and reporting of all cancer clinical trials at the UCCCC; (2) Provide core
resources, expertise in study management, timely activation and completion of trials, and robust quality
control and quality assurance for UCCCC investigators in the conduct of investigator-initiated clinical trials
through central infrastructure within CTSO Quality Unit; (3) Hire, train, and retain a diverse, equitable, and
inclusive CTSO team with opportunities for professional growth and provide ongoing education and training
to staff and investigators to ensure safe and ethical conduct of clinical research; (4) Integrate Community
Outreach and Engagement (COE) and CTSO to improve awareness of clinical research and identify areas
of opportunity to enhance accrual of women, children, and minority cancer patients across the lifespan within
the UCCCC catchment area and beyond.
During the current project period, several strategic and operational improvements occurred. These include:
(1) reorganization and centralization of key functions under newly branded CTSO infrastructure, with an
overall 77% increase in clinical research staff from CY2017 (98 FTEs) to CY2022 (173 FTEs); (2) increased
annual operating budget of the CTSO to $5.73M (compared to $1.13M in 2018) to support new and newly
centralized units; (3) developed innovative pathway programs to attract and recruit new talent to our CTSO
with a focus on diversity, equity, and inclusion within the CTSO; (4) increase in interventional accruals during
this funding period (5,786 in previous funding period; 6,644 in current which includes 3,633 treatment
accruals); (5) growth in minority treatment accruals within our catchment area increased from 30% in CY18
to 34% in CY22; (6) growth in the number of novel IITs which increased from 4.7% to 10.8% of new trials
from 2021–2022; (7) a total of 51 new IITs (out of total of 86 actively open IITs) were open to accrual , and
45 INDs were held by UCCCC investigators, leading to a third of all accruals to IITs; (8) achieved efficient
start-up timelines for national trials (< 31 days) and decreased IIT start-up timelines by 62 days from CY21
to CY22.